Cardiac Effects of Mineralocorticoid Receptor Antagonism after Preeclampsia (CARDAMOM)

PROJECT SUMMARY/ABSTRACT
Preeclampsia, a condition marked by hypertension and systemic endothelial/microvascular dysfunction in late
pregnancy, affects 8% of childbearing U.S. women and is associated with two-fold risk of future material
cardiovascular disease (CVD) as well as premature CVD mortality. The American College of Cardiology and
American Heart Association now recognize preeclampsia as a sex-specific CVD risk factor to guide prescription
of preventive statin therapy. Beyond this focused recommendation, however, specific strategies for CVD risk
reduction in women with preeclampsia are not yet established. Recent preclinical evidence suggests that
preeclampsia induces vascular smooth muscle cell mineralocorticoid receptor (MR) sensitivity that persists
postpartum, promoting hypertension and CVD. Although MR signaling is known to underlie hypertension, MR
activation also promotes cardiovascular, kidney, and metabolic disease via effects that are partially independent
of blood pressure. Work by our team has implicated MR signaling in coronary microvascular dysfunction, a known
predictor of heart failure with preserved ejection fraction (HFpEF) and CVD mortality. Our central hypothesis is
that, among women with prior preeclampsia who subsequently develop chronic hypertension, MR blockade will
promote favorable cardiac remodeling and improve coronary microvascular function, independent of changes in
blood pressure, and thereby reduce CVD risk in affected women. To test this hypothesis, we propose a
randomized, double-blind clinical study in humans. Women aged <55 years with a history of preeclampsia,
current chronic hypertension, and concentric left ventricular remodeling will be randomized 1:1 to receive
eplerenone (mineralocorticoid receptor antagonist) or chlorthalidone (thiazide-like diuretic) with potassium
supplementation for 48 weeks, targeting equivalent blood pressure control in both groups using daily home BP
measurement and 24-hour ambulatory blood pressure monitoring. We will measure coronary microvascular
function (myocardial flow reserve, i.e., hyperemic stress/rest myocardial blood flow) quantified by cardiac
PET/CT (Aim 1) and cardiac structure and function by cardiac ultrasound (Aim 2) at baseline and 48 weeks. We
expect that, compared with chlorthalidone, eplerenone will yield greater improvements in coronary microvascular
function and myocardial diastolic function after 48 weeks of treatment. Additional exploratory endpoints will
include retinal vascular density by optical coherence tomography as an extra-coronary measure of microvascular
health. If our hypotheses are affirmed, these findings would support the targeted use of MR antagonists much
earlier than recommended by current guidelines for the management of hypertension to more effectively prevent
HFpEF and other CVD among women with a history of preeclampsia.

Public health relevance
PROJECT NARRATIVE Preeclampsia, a condition characterized by high blood pressure in pregnancy, is associated with increased long-term risk of developing cardiovascular disease. Our randomized clinical trial will test the hypothesis that activation of the mineralocorticoid receptor promotes cardiovascular disease in women with prior preeclampsia and may therefore warrant a targeted approach to cardiovascular disease prevention for affected women. Among women with prior preeclampsia, we will test the effect of mineralocorticoid receptor blockade on cardiac remodeling and on the coronary microcirculation using multi-modality cardiac imaging.